Understanding the effect of rurality and social risk factors on barriers to care and surgical outcomes.

Background: The Mission Act provides improved Veteran access to care both within the Veterans
Administration (VA) and community systems. An underlying assumption is that faster care with more choices
results in better care. However, care fragmentation is associated with increased length of stay, readmissions,
and mortality. Postoperative complications and readmissions are higher in minority and low socioeconomic
status (SES) patients. Low SES is also associated with frailty, one of the best predictors of 30-day
postoperative complications and hospital readmissions. Despite having a profound influence on health
outcomes, social risk factors are absent from risk adjustment for VA quality measures, further exacerbating
disparities in minority and low SES populations. This strategy may further constrain resources to care for
vulnerable populations, as many Veterans are economically disadvantaged and potentially adding avoidable
costs to care delivery. Another major issue is care fragmentation. Nevertheless, the impact of non-VA care and
care fragmentation is absent in performance metrics. Our goal is to identify social risk factors and levels of
care fragmentation that affect surgical outcomes to inform VA quality metric policy and institutional
resource allocation. We improve upon current practice by joining surgical outcomes data with 1) VA/Centers
for Medicare & Medicaid Services (CMS) claims data, 2) VA fee-basis files to identify encounters outside of the
VA health system and 3) using more granular proxy social risk factors and neighborhood disadvantage.
Significance/Impact: Our significance is modeling surgical outcomes using social risk factors, rurality, living in
a disadvantaged neighborhood and care fragmentation to identify factors contributing to health care disparities
and to inform VA policy. The impact is to develop quality metrics using social risk factors and care fragmentation.
HSR&D priority areas: Rural Health, Health Equity, Health Care Value and Health Care Informatics.
Innovation: Joining diverse data sources to develop predictive models using both traditional parametric methods
and exploratory machine learning techniques to provide clinicians and administrators with outcomes and
economic analyses necessary to change institutional practices to benefit our most vulnerable Veterans.
Specific Aims:
Aim 1: Identify factors affecting surgical outcomes by assessing the contributions of ethnicity, race, SES, place
of residence and care fragmentation to surgical complications, readmissions and mortality
Hypothesis: Using ethnic/racial minority status, SES, place of residence and care fragmentation will identify
important risk factors for postoperative complications, readmissions, and mortality
Aim 2: Assess the impact of social risk factors and care fragmentation on hospital performance metrics for
readmissions and mortality
Hypothesis: Including social risk factors and care fragmentation in risk adjustment models significantly
changes VA hospital performance rankings with respect to readmissions and mortality
Aim 3: Determine the relationship of place of residence, care fragmentation, SES and minority status to acute
and long-term VA surgical health care utilization to inform VA resource allocation
Hypothesis: Low SES, rurality, care fragmentation and minority status are associated with higher VA resource
utilization
Methodology: Quantitative analyses using traditional parametric and exploratory machine learning techniques
performed on diverse datasets to develop predictive models of surgical outcomes using care fragmentation,
rurality and social risk factors risk adjusted for medical comorbidities and applied to VA quality metrics.
Implementation/Next Steps: Deployment of quality metric models using social risk factors and care
fragmentation within the VA system. Adjusting resource allocation to account for social risk factors.

Public health relevance
Patients with social risk factors, including poverty, being a minority, lack of an education, and living in rural areas are all associated with having worse health outcomes and having more difficulties recovering after surgical procedures. We will study the effect of social risk factors and rurality on health outcomes after surgery to identify patients that would benefit from care pathways that help poor people. One problem is that medical records usually do not contain information about social risk factors. We will use multiple data sources to try to determine which social risk factors have the most effect on surgical outcomes. These studies will help us understand outcomes in patients receiving care within and outside of the VA and how to use that data to improve our ability to identify patients that need extra help. In addition, a better understanding of which social risk factors lead to poor outcomes will help us to design care pathways that provide services and treatments that will improve outcomes after surgery.